T32 for Training in Microbiology and Infectious Diseases

PROJECT SUMMARY

This proposal is a new application for five years of funding to support Training in Microbiology and
Infectious Diseases at UC Irvine. The primary objective of this Training Program is to provide doctoral
students with integrated training in three focus areas: 1) microbial structure and metabolism, 2) microbe-­
host interactions, and 3) microbial communities. The rationale behind this training structure is that there
will be tremendous value in individuals with a fluency in these related areas that are vital to combating
and/or exploiting microbes to positively impact human health and the environment. The Training Program
will leverage areas of excellence at UCI in microbial ecology, microbe-­host interactions, and structural
biology to bring together faculty trainers with expertise in microbial pathogenesis, molecular genetics,
metabolism, structure, immunity and infectious diseases, and microbial diversity. The program will be
comprised of 18 well-­funded training faculty (10 women, 8 men) from the School of Biological Sciences
and the School of Medicine at UCI. The faculty mentors conduct research on microbiology and infectious
diseases at the molecular, cellular, organismal, population, and community levels. UCI has a strong
history in the fields of microbiology and infectious disease research, as the Pacific-­Southwest Regional
Center of Excellence in Biodefense and Emerging Infectious Diseases was housed at UCI from 2005-­
2014. The Training Program will ensure that the trainees will be equipped with the necessary tools and
expertise to pursue a productive and independent career in microbiology. In addition to faculty
mentorship, the trainees will benefit from seminars, journal clubs, research in progress talks, and an
annual symposium. Trainees will also receive funds to travel to and present their research at a national
meeting in their field. Finally, UCI is home to the NIH-­funded GPS-­BIOMED program, which will ensure
that trainees have exposure to career development seminars, workshops, and mentorship throughout
their training. The application requests support for three predoctoral trainees, who will be drawn from
students who enroll at UCI through one of several gateway or departmental programs, including the
Cellular & Molecular Biosciences Program, Interdepartmental Neuroscience Program, Mathematical,
Computational & Systems Biology Program, Medical Scientist Training Program (MSTP), and the
departmental Ecology & Evolutionary Biology Program. The mean incoming GPA for this cohort of
students over the last five years was 3.61, reflecting a strong overall academic performance by the
potential trainees. On average over the last five years, 23% of the training-­grant eligible entering
students were under-­represented minorities. UCI has been recognized as a Hispanic-­serving institution
(HSI) and an Asian American, Native American, and Pacific Islander serving institution (AANAPISI), and
the Training Program is expected to reflect this rich cultural and ethnic diversity on the UCI campus.

Public health relevance
PROJECT NARRATIVE This is a T32 proposal for a Training Program in Microbiology and Infectious Diseases at UC Irvine that will provide doctoral students with integrated training in three focus areas: 1) microbial structure and metabolism, 2) microbe-host interactions, and 3) microbial communities. The purpose of the Training Program is to train the next generation of promising scientists to tackle the myriad of scientific and health issues posed by microbes in the community and in infected individuals.